Control of Dendritic Spine Stability via Regulation of a Stable Actin Pool

Project Summary/Abstract As per the guidelines, the research plan includes the project summary/abstract of the funded parent award.

Public health relevance
Project Narrative Abl2 and cortactin regulate actin stability in vitro and are critical for retaining the stable actin pool and turnover in dendritic spines. Depletion of the stable actin pool via disruption of Abl2 or cortactin, or interactions between the proteins, significantly reduces spine stability. This supplement will elucidate the actin-binding interface in cortactin and a novel Abl2:cortactin interface and test their impact on the localization of cortactin and Abl2 and their ability to maintain the stable actin pool in dendritic spines.